Cardioscopically-guided Valve Repair in the Beating Heart

Project Summary
Valvular heart disease is an important health problem afflicting over 2.5% of the US population and, while
surgical repair of native tissue remains the gold standard, the reduced risk of catheter-based interventions
has provided the capability to intervene earlier in the disease process as well as in the sickest patients while
avoiding the risks of cardiopulmonary bypass. The outcomes of transcatheter procedures are not, however,
consistently superior to alternative treatments. For example, those patients receiving transcatheter edge-to-
edge repair of mitral regurgitation benefit from a significantly shorter hospital stay but require follow-up surgery
for recurrent mitral regurgitation substantially more often than those undergoing initial surgical repair. As a
second example, when transcatheter tricuspid valve repair devices are successfully deployed, they
substantially reduce the risk of death compared to medical therapy, but device implantation is successful less
than 3/4 of the time. Optimal patient care should combine the benefits of beating-heart interventions with the
effectiveness and patient-specific tailoring of surgical repair. We hypothesize that the fundamental limitation
is that catheter-based delivery greatly reduces the interventionalist's capability to visualize and to intuitively
control device delivery. To address these issues, in the prior funding period, we created the first cardioscopic
imaging systems for performing valve repair inside the blood-filled beating heart. We demonstrated that
cardioscopy can improve local visualization to such a degree that certain procedures can be accomplished in
minutes rather than hours. We also created a joystick-controlled robotic catheter that provided an intuitive
control interface and a standardized platform for performing valve repairs. These results were achieved using
transapical access to the left ventricle of the heart. For broad adoption, we need to further develop this
technology to enable its percutaneous delivery via the femoral vein. Percutaneous delivery presents
significant new challenges since the cardioscopes must be compact during vascular navigation and then
enlarge for valvular imaging. Furthermore, to enable broad adoption of transcatheter valve repairs and to
make those repairs as effective as surgical repairs, the robotic catheter should not just make a single repair
technique easy to perform, but instead should allow a clinician to easily perform a sequence of complementary
repairs as is now done in surgery. In Aim 1, we will overcome the challenges of percutaneous cardioscope
delivery by creating balloon-based cardioscope designs and demonstrating this technology for the specific
repair of mitral chordae implantation through ex vivo and in vivo testing. In Aim 2, we will design a modular
robotic catheter platform to create the capability for a single delivery system to be used to perform two
important complementary mitral valve repairs, chordae implantation and annuloplasty, through a standardized
joystick-based interface. We will evaluate this system using ex vivo and in vivo experiments.

Public health relevance
Project Narrative Valvular heart disease affects over 2.5% of the US population. While catheter-based valve interventions substantially decrease patient risk in comparison to open surgery, existing catheters and imaging technologies cannot replicate the dexterity and visualization afforded by open surgery. To enable more effective and more complex beating-heart procedures, we propose to develop cardioscopic imaging and robotic catheter technology that can be delivered through the vasculature.